Understanding the Selective Mechanism of Tau Propagation in Alzheimer's Disease Through Multi-layer Spreading Pathways

Abstract
Alzheimer’s disease (AD) is characterized by the propagation of tau aggregates throughout the brain. Tremendous
efforts have been made to the development of tau biomarker, aimed at advancing our current understanding of AD
etiology and facilitating early diagnosis in routine clinical practice. Since current pathology imaging technologies
only provide a spatial mapping of tau pathology, many biomarker studies have to link stereotypical patterns
of tau accumulation to the complex pathophysiological mechanism of disease progression. Recently, we have
made significant progress to characterize dynamic process of tau spreading in a principled potential energy
transport model that allows us to uncover the region-to-region spreading pathways of tau aggregates from the
longitudinal tau-PET scans. However, our current method is limited to a single-layer scenario to the extent that the
spreading pathways follow either the wiring topology of white matter fiber bundles (referred to as "air-based") or
the folding patterns on the brain cortex (referred to as "road-based"), despite the fact that air-based and road-based
transport might collaboratively contribute to the whole-brain tau propagation. To address this limitation, we will
develop a multi-layer neural transport equation to jointly model the spreading of tau aggregates throughout the
brain network and along the brain cortex in Aim 1. Furthermore, we introduce the notion of optimal control to
characterize the interaction between air-based and road-based tau propagation, which allows us to uncover a
system-level understanding of the selective mechanism in multi-layer tau propagation in Aim 2. By capitalizing
on large scale of existing neuroimaging data, we will explore a set of open neuroscience questions regarding
tau propagation in Aim 2, including dynamic coupling patterns, region vulnerability, and system criticality.
Meanwhile, we will evaluate the clinic value of our multi-layer model in predicting the future tau accumulation
and the risk of developing AD. The success of this project has the potential to offer valuable insights into AD
etiology, thereby enhancing our understanding of AD progression and refining treatment strategies. Moreover,
the computational tools can be readily applied to other biomarker studies in neurodegenerative diseases. This
initiative lays the groundwork for future research into advanced diagnosis and tailored personalized treatment for
AD.

Public health relevance
Project narrative This multidisciplinary two-year research project is designed to understand the mechanisms of how tau pathology spread throughout the brain. To that end, we will develop a novel multi-layer neural transport model and an explainable deep learning approach to characterize the dynamics of tau propagation throughout brain network and cortical areas. By capitalizing on a large-scale existing neuroimages, we will explore the selective mechanism of tau propagation at a system level using the notion of control theory.